From Pain Resilience Genes Toward Therapeutic, Non-Opiate Modulation: An iPSC-Based Approach

Safe and effective treatment for chronic pain is an unmet medical need, which in turn has contributed to the
opioid crisis. The experience of pain varies from person to person, with some individuals relatively resilient to
pain compared to others. Individual-to-individual variation in pain, while observed in the clinics, has not been
accurately modeled in the laboratory nor has its mechanistic underpinnings carefully examined. This is partially
because pain involves detection by the peripheral nervous system and perception in the central nervous
system, and may be modulated by many factors including genetic, epigenetic, environmental and social. Our
studies of blood relatives with inherited erythromelalgia (IEM) with varying degrees of pain despite carrying the
same Nav1.7 mutation (S241T) have allowed us to identify modulatory gene variants/mutations expressed in
sensory neurons using whole exome sequencing as modulators of pain in these patients. In this proposal, we
will build upon our discovery of “pain resilience genes” and evaluate the potential of pharmacological
modulators of Kv7 channels to reduce hyperexcitability of human sensory neurons derived from genetically
validated subjects with chronic pain, as a way to identify safe and effective strategies that steer away from
opioids in the treatment of chronic pain.

Public health relevance
Chronic pain is a major challenge for Veterans with nerve and spinal cord injury, traumatic limb amputation, burn injury, and peripheral neuropathy. Current treatments for pain are largely ineffective or only partially effective, and can be addictive, which in turn has contributed to the opioid crisis. Rehabilitation of Veterans with chronic pain would be substantially enhanced by the development of more effective, non-addictive treatments for pain. The proposed work builds upon our discovery of “pain resilience genes” to evaluate the potential of pharmacological modulators of Kv7 channels that reduce hyperexcitability of human sensory neurons derived from genetically validated subjects with chronic pain, as a way to identify safer and more effective treatment strategies.